METABOLISM OF LEUKOTRIENE B4 IN MYELOPROLIFERATIVE DISORDERS

To study leukotriene B4 metabolism ex vivo and in vivo in patients with myeloproliferative disorders and relate this to qualitative and quantitative tests of neutrophil function.